Chemical approaches for detecting S-nitrosothiols

DESCRIPTION (provided by applicant): Nitric oxide is a cell-signaling molecule involved in a number of physiological and pathophysiological processes. Modification of cysteine residues by nitric oxide, i.e. S- nitrosation, changes the function of a broad spectrum of proteins. This reaction represents an important post-translational modification that transduces nitric oxide- dependent signals. However, the detection and quantification of S-nitrosation in biological samples remains a challenge because of the lability of the S-nitrosation products: S-nitrosothiols (RSNOs). Our group recently developed a series of new reactions for RSNOs, which include bis-ligation, reductive ligation, and reductive elimination (to form dehydroalanine). These reactions selectively target on RSNOs and convert them to stable/detectable products. Based on control experiments, we hypothesize these reactions can be used to design new methods for the detection of RSNOs. In this project, we plan to pursue the following four Specific Aims: (1) to study bis-ligation based methods for detecting protein S-nitrosation; (2) to study reductive ligation based methods for detecting protein S-nitrosation; (3) to study dehydroalanine formation from S-nitrosocysteines and the applications in the detection of protein S- nitrosation; and (4) to validate the applications of new RSNO detection methods in biological systems. These studies will advance the understanding of the chemical and biological properties of RSNOs and permit studies of S-nitrosation-related nitric oxide signal transducation in complex systems.

Public health relevance
PUBLIC HEALTH RELEVANCE: S-Nitrosation of protein cysteine residues plays important roles in physiology and pathophysiology, while the detection of S-nitrosation is still a challenge. The research proposed here will provide new insights into the chemistry of S-nitrosation and lead to new techniques for the detection of S-nitrosation in biological samples, which should have great impact on biomedical research. Project Narrative S-Nitrosation of protein cysteine residues plays important roles in physiology and pathophysiology, while the detection of S-nitrosation is still a challenge. The research proposed here will provide new insights into the chemistry of S-nitrosation and lead to new techniques for the detection of S-nitrosation in biological samples, which should have great impact on biomedical research. __SpecificAimsTextDelimiter__ A. Specific Aims Protein S-nitrosation, also referred to as S-nitrosylation-i.e. converting cysteine residues (SH) to S-nitrosothiols (RSNO), is an important post-translational modification analogous to phosphorylation or acetylation. This biological reaction is thought to occur as a result of biological nitric oxide (NO) forma- tion and has been known as a mechanism by which NO can transmit signals both within and between cells and tissues. However, the detection of S-nitrosation remains a challenge because of the lability of the SNO moiety and the lack of specific reactions to convert unstable SNOs to stable and detectable molecules. Our long term goal is to develop a toolbox of bioorthogonal reactions of RSNO and apply them to study protein S-nitrosation in biological systems. Toward Scheme 1 H O this end, we have recently discovered three interesting reactions O N N using organophosphine substrates (Scheme 1): 1) bis-ligation of R S H RSNOs to form disulfide-iminophosphorane products; 2) reduc- S S P Ph tive ligation of RSNOs to form sulfenamide products; and 3) re- Ph R N P Ph bis-ligation ductive elimination of S-nitrosocysteines to form dehydroalanine O Ph products. All three reactions proceed rapidly with good yields un- O O H der mild conditions. We hypothesize these reactions can be used H O RO N N to develop new methods for the detection of RSNOs in biological N N P Phh H O H S systems, especially for proteomic studies of protein S-nitrosation. S NO reductive ligation NH A highly skilled team of investigators (Xian, Lancaster, Whorton, Me2N O PPhPh and Tao) has been assembled to carry out this project. The pre- liminary data obtained from this group forms a solid basis for this reelidmuicntaitvieon PPhPh H O project. N N H We plan to test our hypothesis and accomplish the objectives of this application by pursuing the following specific aims: Aim 1. Study of bis-ligation based methods for detecting protein S-nitrosation. We propose to pre- pare a series of bis-ligation based SNO probes, including biotin-labeling reagent, soluble polymer-based reagents, and alkyne-linked reagents. The efficiency of these reagents will be evaluated using standard SNO protein models. This research will provide a basis for further applications of these probes in more complex biological samples, such as cell lysates. Aim 2. Study of reductive ligation based methods for detecting protein S-nitrosation. We will ex- plore the applications of reductive ligation in protein systems. Given the potential stability problem of cur- rent reductive ligation products, i.e. sulfenamides, we plan to optimize the reductive ligation strategy based on structural modifications to the substrates. Alterative reductive ligation processes will also be examined. These studies will provide new insights into bioorthogonal reactions of RSNOs, potentially leading to reagents with properties better suited to complex biological samples. Aim 3. Study of the dehydroalanine (Dha) formation from S-nitrosocysteines and applications in the detection of protein S-nitrosation. We plan to further study the phosphine mediated transformation from S-nitrosocysteines to Dha. The proposed research will lead to the identification of suitable reagents for Dha formation from protein SNO moieties. The resultant Dha derivatives would allow a straightfor- ward chemoselective incorporation of various reporter molecules on proteins. Aim 4. Applications of new SNO detection methods in biological systems The new methods devel- oped in Aims 1-3 will be examined in complex biological systems including cell lysates and tissue sam- ples. These experiments will be carried out in collaboration with Lancaster, Whorton, and Tao. As we have already identified lead reagents for Aims 1-3, the experiments designed in Aim 4 will be carried out during Year 1. The information obtained from these studies will help us to further refine the reagent de- sign. A comparison of results from this work to those obtained using other methods will provide new in- sights into SNO formation in real biological systems.